The Food and Drug Administration's Education and Outreach Program Targeting School-Aged Childrend

ABSTRACT: Food and Drug Administration’s Education and Outreach Program Targeting School-Aged Children OBJECTIVE: The objective of the proposal is to demonstrate how Graduate School USA will provide year-round program support for FDA CFSAN’s educational outreach programs for school-aged children, using FDA-approved materials to convey food safety and nutrition message. The full-year program will include train-the-trainer programs; promotion of materials through advertisements, listservs and websites; and distribution of FDA materials at conferences and to classroom teachers and other educators. MATERIALS AND METHODS: Promotion of the Professional Development Program in Food Science, based on the Science and Our Food Supply curriculum, will be accomplished through print advertisements in educational publications; at educational conferences and participant- led workshops; through state and regional listserv notifications; and via the teachfoodscience.org website. The online application, located at teachfoodscience.org, is managed by Graduate School USA. Applications will be reviewed by master teachers/program facilitators; selection is based on a scoring rubric, resulting in selection of 37 educators with the highest scores being selected as summer 2016 participants. Those teachers are brought to Washington, DC, for a week-long, residential program that incorporates hands-on training at University of Maryland Microbiology labs, as well as in classroom training at Graduate School USA. Visits to the USDA Agricultural Farm and the FDA to discuss food safety and nutrition with their scientists is an integral component of the week. Summer participants teach components of the Science and Our Food Supply curriculum to their students in the fall; in December, the group reconvenes with the facilitators for a day-long training symposium at a regional NSTA Conference to review best practices and how modules fit within Science, Technology, Engineering Math (STEM) curriculum components, and to plan agendas for their mandatory train-the-trainer workshops, to take place before June 30, 2016. Ongoing support of the summer participants is provided by the Graduate School USA point of contact, and supplementary materials are forwarded to these teachers for their train-the- trainer workshops. Additional support is provided for teachers who make contact through websites, teacher-led workshops, and at educational conferences. FDA material orders are placed on a regular basis from teacher requests.

Public health relevance
PROJECT NARRATIVE Food and Drug Administration’s Education and Outreach Program Targeting School- Aged Children The FDA Center for Food Safety and Applied Nutrition (CFSAN) engages educators in the promotion of educational outreach programs as part of its overall mission to promote and protect public health. Since 1999, CFSAN's Education Team has worked with the National Science Teachers Association (NSTA) to encourage science teachers across the country to integrate food science and food safety into middle level and high school classrooms and laboratories. The product of this collaboration, the Science and Our Food Supply Curriculum, targets education, communication, and training issues in food safety and nutrition that educators can teach in their classrooms and which can also be promoted at educational conferences and fairs. The curriculum content is linked to specific National Science Education Standards to help teachers integrate this content into their existing class material and complements FACS standards as well. By improving their scientific understanding and health literacy related to food safety and nutrition, this curriculum has far-reaching benefits for students. The promotion of safe food handling and healthy food choices can improve their personal health status, as well as contribute to safer food handling for those students who later are employed in food-related jobs. NSTA has been an invaluable partner in this program, because it is uniquely qualified to promote science content to middle level and high school science teachers nationwide. Not only is NSTA intimately knowledgeable about all aspects of the program, having partnered in developing the initial concept and in all phases of planning through to final review and execution, but it also has credibility with science teachers that legitimizes the educational value of the curriculum. NSTA is the largest organization in the country representing science teachers. Through its organizational structure and personal contacts nationwide. NSTA conferences and communication vehicles are in the best position to successfully and credibly market this program to science teachers. This proposal will address continued support of the Professional Development Program in Food Science, a year-round program that encompasses a variety of related tasks. The program requires continuous attention to cover the various stages of teacher selection and residential training, as well as follow-up training and management of the selected participants. Additional activities include management of exhibiting FDA programs and materials at educator conferences and distribution of food science education materials to educators throughout the nation. Additional components include advertisement of the professional development program as well as the Science and our Food Supply curriculum through print and non-print media; maintenance of the teachfoodscience.org website; and provision of additional online resources through the NSTA Learning Center and via the FDA and Graduate School websites. The FDA cooperative agreement announcement requires the grantee to “provide 37 teachers for one school year to extend CFSAN’s reach into additional U.S. schools. The selected 1 grantee must train and ensure that these 37 teachers will use the FDA curriculum Science and Our School Supply (SOFS), which has been approved by FDA Scientists.” Contracting methods for this program have evolved over the years, from the Interagency Agreement, to Mobis Contracts, to the current Cooperative Agreement. Budget preparation and calculation for each of these contracting mechanisms differs, presenting challenges for each method. Upon close review of the new contracting mechanism and the real-cost expenses necessary to provide continued high-quality, responsive support for the program and ensure its positive reputation, there are many unknown variables that necessitate a shift in the annual number of participants who can successfully complete the program. Based upon the variables and extensive calculation, we suggest that the range be shifted from 37 teachers to “between 32 and 37 teachers.” A large variable in this project is the travel budget – hotel rates and airfares continue to escalate. This program’s outreach is to all teachers in the US as well as in DoD schools overseas. Concerted efforts have been made in recent years to apprise teachers in rural and underserved communities about the professional development program and the Science and Our Food Supply curriculum. As we have become more successful in attracting qualified educators from these rural areas, our expenses have increased. The distance between homes in rural areas and the nearest major airports is greater than that of a teacher living in a metropolitan suburb; flights from rural airports are limited and in turn, more expensive, than those from major airports. In addition, locations of the NSTA regional conferences for the next 4 years are unknown, which could result into higher fares than anticipated for the regional December enhancement training that takes place in conjunction with this conference. Because future costs are unpredictable, Graduate School USA proposes that year one of this agreement be based on participation of 32 teachers, with increases in following years, pending available and/or additional funding. Teacher Selection/Obligations Selected teachers sign contractual agreements to teach the Science and Our Food Supply curriculum in their classrooms and to conduct a train-the-trainer workshop for science and FACS teachers in their region on how to successfully use the curriculum with their students. With this contractual obligation, teachers ensure there is ongoing promotion and support of FDA materials and programs in their educational communities. The agreement is also signed by the participant’s principal, as an acknowledgement of the teacher’s contractual obligation to FDA to teach the curriculum in their school, participate in two training sessions (one of which could necessitate the teacher’s absence from school for one day) and to teach a train-the-trainer workshop based on the curriculum, in their school district. All participants receive the Science and Our Food Supply curriculum when they arrive in DC for the training, and additional copies are sent for their professional development workshops. 2 Professional Development Program in Food Science The program begins with a rigorous, week-long residential training for middle level and high school science and family and consumer science (FACS) teachers, utilizing Science and Our Food Supply as the core curriculum and uses other FDA produced supplementary materials. The program is selective, i.e., teachers must apply and their application and essays are judged by a panel of peers who are master teachers, program facilitators and previous participants. The selected teachers sign contracts that they agree to teach the FDA content throughout the year, as well as teach the curriculum in a “train-the-trainer” forum for educators within their district/state. The selected teachers are brought to Washington, DC, in mid-July for an intensive six-day “train-the-trainer” program, led by master teacher/facilitators who instruct them on best practices and methodology to teach the Science and Our Food Supply curriculum, the basis of instruction. Teachers chosen to participate in the program are briefed on the latest research on food safety, food microbiology, epidemiology, and nutrition from leading FDA and USDA officials, and meet with FDA scientists who demonstrate/explain their work, as teachers tour their laboratories. In addition, the teachers participate in field trips to see food safety in action on a research farm and spend extended hands-on time at the University of Maryland microbiology labs, receiving instruction from their skilled faculty, and performing lab work presented in the Science and Our Food Supply curriculum. Training Locations Visits (based on 2015 program) will include but are not limited to USDA Agricultural Farm, Beltsville, MD; University of Maryland Microbiology Labs, College Park, MD; Smithsonian Museum of American History (Transforming the American Table: 1950 – 2000); and FDA/CFSAN offices and labs in College Park, MD. Post July Training Commitments Following their intensive week of training in Washington, DC, the participants fulfill their requirement to teach the curriculum to their students, and begin preparations for their day-long in-service workshop for other science and FACS teachers in their school districts. The goal is to introduce food safety and nutrition lessons to their colleagues and to train them on successful use of the Science and Our Food Supply curriculum in their classrooms. To date, 620 teachers have completed this week-long program, reaching approximately 13,000 teachers and more than 7 million students across the country. Teachers in this program have represented all 50 states, the District of Columbia, the U.S. Virgin Islands, the Commonwealth of the Northern Marianna Islands (CNMI), Guam, and Puerto Rico. In addition to the one week training, CFSAN provides a single-day training symposium for the participants at a regional (December) NSTA conference. The Graduate School USA POC will assume the responsibilities of coordinating this all-day training symposium for the participants, led by the four facilitators (2 middle level and 2 high school) who directed the summer training. This enhancement training program provides teachers an opportunity to share feedback on their use of the Science and Our Food Supply curriculum with their students, share appropriate 3 curricular materials that relate to food science, food safety and nutrition, and prepare for their own “train-the-trainer” professional development programs for their peers. Sample agendas are planned and discussed, and lessons showing integration of such FDA-related materials as the popular Food Facts on Allergies, Sodium in Your Diet, Gluten and Food Labeling, and What Consumers Need to Know about Food and Water Safety During Hurricanes, Power Outages and Floods are shared. Ideas for use of these and other FDA Materials are provided that tie them with Science, Technology, Engineering and Math (STEM) and Common Core standards. Throughout the year, teachers request materials from the FDA POC for classroom and workshop use; many teachers have opportunities for multiple presentations at state and area conferences, local Professional Development programs, health fairs, and parent-teacher meetings. The FDA is consistently their first resource for research/content through the abundance of information that can be found through the FDA/CFSAN Education Resource Library. It is critical to the success of this program that the FDA Professional Development Program in Food Science differentiate itself from the crowd of corporations and trade associations who compete for the attention of science teachers. Effective advertising that well-represents the content in attractive formats with key phrasing that emphasizes the educational quality and scientific expertise of the curriculum is within the purview of the Graduate School and will assist with widespread dissemination of FDA materials as well as the curriculum. Graduate School USA shall also be responsible for arranging the program advertisement to science and FACS teachers through teacher journals appropriate for both disciplines, listserves, and in web-based formats. In addition, the Graduate School USA POC shall oversee the coordination associated with exhibiting at the fall 2015 NSTA conference (the all day enhancement training symposium will take place at this same location/time in Kansas City, MO), the National NSTA Conference in spring, 2016 (Nashville, TN), as well as the Association of Family and Consumer Science Educators (AAFCS) conference that takes place in June, 2016 (Seattle, WA). APPROACH: In-Person Training Program In support of the FDA Professional Development Program in Food Science, the Graduate School USA will plan and facilitate conferences/meetings at FDA and non-FDA locations; coordinate travel and per diem arrangements; provide web-based registration and tracking capabilities; handle various forms of correspondence with meeting/workshop participants; plan and coordinate meeting exhibits; and prepare and provide onsite meeting materials, support staff, and technical support. Each training program consists of the following seven key stages, which are based upon the summer 2015 program: 1. Program advertising and promotion: fall 2015 to spring 2016 2. Review of up to 300 teacher applications: winter - spring 2016 3. Week-long summer program for between 32-37 participant teachers and 4 master teacher facilitators to be held in July 2016 4. Incorporation of food science in teachers’ classrooms, mailings, and teacher correspondence: from September 2015 through September 2016 5. Plan and conduct a one-day enhancement training symposium at the area NSTA Conference. (December 5, 2015 -Kansas City, MO) 4 6. Support Teacher Training: teachers train an average of 20 teachers in their region of the country, beginning winter, 2015 through June 30, 2016 7. Web communication and ongoing support for teachers asked to present this program at their State and regional teacher conferences. This proposal addresses the following tasks, as they relate to the stages cited above. Stage 1: The Graduate School USA Point of Contact (GS POC) will facilitate teacher recruitment for an annual summer training program. The POC will create and coordinate advertising in targeted correspondence, e.g., listservs to School Administrators and Science Department Heads as appropriate, securing a professional discount for all advertisements and maintaining the capability to revise any artwork for advertisements upon short notice. The GS POC will update and post online the application form and maintain ongoing contracts with Master Teachers (approved by the FDA PO) for continued consultation through the year for all issues related to changes and enhancements within the Food Science Curriculum program. Stage 2: The GS POC will manage the peer review selection of summer program teachers by completing the following tasks: a. Select a panel of master teachers (FDA PO approved) to review applications for the summer program. b. Contract with master teachers to include remuneration for applicant review and teaching during the Summer Workshop. c. Establish a registration and tracking system for review of up to 300 applications per cycle. d. Establish selection criterion for applicants and create evaluation guide. e. Online review for peer panel; GS POC will ensure that all required documentation for each applicant is posted. f. Provide access password/instructions to middle and high school reviewers, including deadlines for review completion to GS POC. g. Tabulate all application scores and convey results to reviewers (establish criteria if ties occur). h. Update the acceptance response letter and notify all teachers via email of application status on deadline date (accepted or declined); send acceptance packets to all who have been selected for participation. i. Begin processing acceptance responses that include sign-off of principal/administrator to support his/her teacher’s participation during the year as well as of the workshop activities. Stage 3: The GS POC will handle all logistics for the 2016 summer training programs, including the following tasks: a. Select and contract for lodging (no later than December of the preceding year -- government rates, tax exempt) and audiovisual service in a convenient downtown DC location in mid-July. The 2015 hotel is the Holiday Inn Capitol in Washington, DC, across the street from the Graduate School USA. b. Arrange with Travel Agency for easy method for individual bookings of air and/or train travel for summer workshop program for between 32-37 teachers plus 4 facilitators. 5 c. Arrange for two all-day and one half-day classrooms at the Graduate School USA’s training facilities (across the street from Holiday Inn Capital). This program concludes on Saturday at 5:00pm. d. Arrange and contract for daily bus service for group transport to USDA Agricultural Farm, Beltsville, MD; University of MD, College Park; FDA CFSAN, College Park, MD; and, if required, another food safety-related facility in the metropolitan area. e. Provide capability and payment for FedEx shipment (up to 2 boxes per person) of materials provided to participants throughout the week; capability will include international FedEx for participants who teach in American schools overseas. f. Contract with two master teachers and two junior facilitators to lead the 1-week training program as well as the enhancement training symposium in December, and provide appropriate stipends upon completion of the two trainings. g. Provide mechanism for reimbursing government per diem for participants and facilitators, and for local transportation between home, airports, and hotel in DC. h. Arrange for travel, lodging, government per diem. i. Create participant roster. j. Order and assemble conference notebooks. k. Prepare all supplementary materials for the summer workshop. l. Order and prepare graduation certificates for individuals participating in the week-long workshop. m. Provide/document Continuing Educations Units (CEUs) for program participants who request them. n. Email the following information to attendees: 1) Travel Agency contact and update on how to make travel arrangements 2) Emergency Contact Form 3) Housing and Travel Form 4) Draft Agenda 5) Contact Information Form 6) List of participants 7) W-9 form Distribute the following information to attendees during the workshop: 1) Name Badges 2) Travel/Per Diem Voucher 3) Workshop Approval Form 4) Evaluation/Feedback Form 5) Advance Budget Workshop Form 6) Attendee Roster 7) CEU Form 8) Application for credit/workshop professional development documentation 9) Prepare/administer/tabulate pre- and post-assessments. Stage 4: The GS POC will support summer program graduates as they return to their schools and incorporate the food science content into their classroom and laboratory curricula. The GS POC will send an individualized press release to each teacher to distribute to the local media that announces their completion of the FDA Professional Development Program in Food Science. a. Review and process travel reimbursements for payment. b. Process payment for University of Idaho graduate credit requests 6 c. Ship requested number of Science and Our Food Supply kits to each participant’s school, along with appropriate outreach materials such as the following Food Facts: Read the Label Outreach Manual; Foodborne Illness-Causing Organisms in the US Read the Label Bilingual Posters; Eating Outdoors Food Facts, and Food Safety for Moms-to-Be kit. d. Prepare Graduate School USA CEU certificates for all participants. e. Create and send individual Press Releases to each participant. f. Prepare pre- and post-assessments as well as tabulate upon completion. g. Purchase/prepare/send flashdrives with all of the summer photos, as well as any slide shows permitted by the individual speakers. h. Follow up: 1) Send individualized letters to each participant’s principal, reiterating thanks for support of the teacher and the program and providing a reminder about approval to allow leave time for teachers to attend the December Enhancement Conference 2) Workshop Approval Forms 3) Tabulate Evaluation/Feedback Stage 5: The GS POC will make all necessary arrangements for the December enhancement training (4 master facilitators + between 32-37 teachers), a one-day, follow-up training for the summer workshop participants and their facilitators, to take place in conjunction with the December Regional NSTA Conference in Kansas City, MO. Tasks include the following: a. Contract for lodging for 2 nights for summer workshop participants, facilitators, and other representatives. b. Notify all participants of dates and location of the enhancement training and process their responses to include arrival and departure dates and instructions for how to make their travel arrangements. c. Arrange with hotel for master account payment for rooms and for audio-visual equipment. d. Provide mechanism for reimbursing government per diem for participants and facilitators, as well as reimbursement for local transportation. e. Provide duplication services and dissemination to each participant of any materials gathered onto flashdrives during the summer training. f. Arrange for all individual travel, lodging, per diem. g. Secure, prepare, and manage the meeting space at the hotel. h. Email to the attendees: 1) Information to make travel arrangements with the travel Agency 2) Housing & travel form 3) Agenda i. Update participant roster. j. Prepare travel vouchers. k. Prepare name badges. l. Post Training: 1) Process travel reimbursement requests. 2) E-mail updated contact list to attendees. 3) Work with Master Facilitator to receive and post &/or email group project feedback to participants on specially-created Edmodo site. 7 Stage 6: The GS POC will support the train-the-teacher events through the following tasks: a. Arrange for any additional kits or FDA materials to be sent to teachers (as requested) for their individual classroom presentations. b. Provide ongoing guidance to teachers as they move toward completion of their peer workshop presentations. c. Arrange an internal approval mechanism and the capability to provide advance payment of up to $500 for STEM (classroom/laboratory materials) to be used in conjunction with the required presentation of the food safety curriculum. d. Process invoice/check request for $500 material stipend for each teacher. e. Ensure that all receipts for advance $500 are received with final report. f. Prepare and mail $500 honorarium per teacher upon receipt of each participant’s final report and financial accounting. Stage 7: The GS POC will provide follow-on support to facilitate communication among the participating teachers and to promote the food science program with the following activities: a. Maintain www.teachfoodscience.org website for the FDA-NSTA program for the promotion of the materials. b. Maintain contact with NSTA to promote the program and curriculum through the use of existing listservs, targeting distribution to the intended audience. c. Maintain contact with the American Association of Family and Consumer Sciences (AAFCS) to promote the program and curriculum through targeted listservs. Exhibits and Education Material Dissemination A component of the GS POC’s responsibilities as National Training Coordinator for the year- round program is overall management of curriculum content delivery as well as other FDA materials, to science and FACS teachers nationwide. This is accomplished through exhibiting at two NSTA Conferences – one national and one regional, and at the National AAFCS Conference. Responsibilities include the capacity to house, store, ship and manage the program exhibit and to promote and disseminate food safety and nutritional educational material including the Science and our Food Supply curriculum. Goals of these efforts include making educators aware of the Professional Development Program, as well as to generate orders for the curriculum annually. The GS POC will: 1. Select exhibit staff approved (by FDA PO) for each exhibit location. 2. Plan marketing of the FDA food safety and nutrition program materials during the conferences. 3. Manage the exhibit materials, to include the following tasks: a. Prepare registration forms and disburse payment to Conference organizer, e.g. NSTA or AAFCS, for booth rental at each conference. b. Work with FDA and exhibitors to determine the most appropriate materials (and quantities) for each exhibit site. c. Order materials from the FDA Warehouse for shipment to each of the conference locations. Orders for FDA materials must be made in a timely fashion to avoid express shipping. d. Overall management of traveling FDA exhibit to include: 1) Evaluation of overall exhibit design. 8 2) Flexibility for change within overall exhibit design. 3) Access to art design professional to either modify existing exhibit and/or completely redesign the exhibit and its components, as needed or required. 4) Ability to house the exhibit between conventions. 5) Ability to securely send out exhibit in a timely manner to all exhibit sites. 6) Maintain upkeep of the exhibit and reorder any necessary replacements in a timely fashion. 7) Provide guidance and methods for exhibit return from each location. 8) Ongoing data entry of teacher request orders for materials from the FDA warehouse via use of FDA’s online ordering system. Orders are received via advertisements in various publications, online requests from FDA, NSTA, and Graduate School USA websites, as well as from conference requests. 9) House/manage an online registration/request system for the Food Science Program at: teachfoodscience.org. 10) Prepare individual forms for various order/payments related to exhibit vendors, including the Credit Card Authorization Forms and Pre- Registration Exhibitor Badge Forms. 11) Complete orders for exhibit booth arrangement through the conference management service, e.g., GES Exposition Services, to include:  Furniture  Carpet  Materials handling  Cleaning/janitorial services  Electrical  Shipping 12) Pack /order/ship materials and supplies to the exhibit company warehouse, including a minimum of FDA bags filled with at least 10 different FDA Materials appropriate for middle level and high school classes; the Science and Our Food Supply Curriculum; K-3 program; 4-6 Fight Bac Curriculum, hard copy descriptions/applications for the Professional Development Program, FDA Materials Order Forms, Labelman CDs, promotional cutting boards and the exhibit backdrop. 13) Oversee the exhibit onsite, including:  Check-in at exhibitors’ booths (Pick-up badge and information)  Confirm all shipments have arrived.  Confirm that all exhibit company orders have been fulfilled correctly.  Set-up exhibit  Distribute giveaways, applications, order forms, and other materials.  Collect all completed requests for FDA educational materials.  Pack all remaining materials at the end of the exhibit timeframe.  Prepare labels and adhere to remaining materials for shipping.  Arrange for exhibit material pick-up at the end of the exhibit timeframe. 14) Post-conference:  Check all returned exhibit materials for any damage.  Prepare inventory of all the shipped items.  Review all exhibit company provider billing, and hotel billing.  Process all order requests. 9 Strategic Planning and Developmental Needs The GS POC will facilitate, identify and prioritize technical assistance and development needs, and throughout the year, develop strategic and project plans, and allocate resources to coordinate FDA training program components for US teachers. All plans will actively incorporate FDA’s food safety and nutrition curriculum and show teachers how they can integrate the various training components into lessons that are compatible with regional standards. Local Travel The Graduate School USA POC will research various local bus companies and select one based upon the following criteria: • Capacity to seat 46 participants • Recent model vehicles (equipped with GPS) in excellent running order with operating air conditioner and microphone • Multiple vehicles in their fleet for immediate back-ups in case of emergency • Commitment for one dedicated driver for the entire week who will preplan the travel route upon receipt of itinerary from GS USA Master Teachers Contracts to facilitate the training will be sent to FDA-approved master facilitators for the summer course. Contracts will also be sent to University of Maryland Microbiology professors/instructors, who will instruct the summer course participants in how to conduct labs from the Science and Our Food Supply curriculum. All teachers in this summer training course will have hands-on experience in conducting at least four of the lab experiments featured in the curriculum. Throughout the weeklong training course, one of the facilitators will serve as a photographer, capturing the most essential presentations and candid photos of the various presentations and field trips. Within one month, a master file will be created and edited; the files will be duplicated on flash drives and sent to each teacher by the end of September. Materials Science and Our Food Supply will be the core curriculum for the weeklong training program. The Graduate School USA POC will ensure that copies are ordered for each participant. Additional materials for the weeklong training course will be prepared with FDA guidance and approval. Typical materials include: • Three-ring binder, separated into 12 tabs with agenda • Speaker bios and presentations • Participant roster • Additional materials deemed appropriate by FDA as they relate to food safety and nutrition, such as chapters from the Dietary Guidelines for Americans, Healthy People 2020 Objectives, FDA/NSTA online tutorial information, and recent news articles about food safety and nutrition. 10 • Name badges for all participants and speakers. • Folder that includes sample budgets, promotional flyers, web resources. Participants will learn about spending guidelines for a $500 STEM materials and lab stipend, provided to enhance their workshop presentations (each teacher will present a peer workshop to at least 20 teachers before June 30 of the following year. If a teacher is unable to meet the quota, they will provide rationale). In addition, participants’ final program criteria includes submission of a final program report (to GS USA POC), as well as all receipts for materials purchased with their stipend, their participants’ workshop evaluations, and their individual pre/post assessments. Upon receipt and review by GS USA POC, they will receive a final honorarium of $500. CEUs Graduate School USA, as an educational institution, will provide the teachers with 4.2 CEUs for the one-week course (a total of 42 contact hours). Certificates will be presented to all participants. Summer course participants may also receive graduate credits through an agreement with the University of Idaho. (There is no cost to FDA or to GS USA.) This course is approved by the University of Idaho for two graduate credits. The nominal cost to participants is $120 for the two credits. Students must register separately with the University; registration forms will be provided on the first day of the training class. Press Release All participants will receive an individualized press release (pdf) to submit to their school districts and local press. The release will feature their name, school, city, and state. The press release will be approved by the FDA COR before it is sent out during the first week of August 2015. Assessment Reports All teachers will take a pre-assessment to measure their current knowledge of food safety and nutrition; a post-assessment will take place on the last day. Tabulation of the summer participants’ pre-and post-assessments will be provided to the FDA POC within three days of completion of the summer program. All participants must include pre-and post- assessments for their workshop participants and submit them to the GS POC upon completion of their workshop for tabulation. Management of the Distribution of Food Science Curricula and Materials The GS POC will make arrangements for distribution of all curricula and materials throughout the contracted time. Online requests from the teachfoodscience.org website, as ...